Addressing Misinformation to Promote Equity in Prostate Cancer Care

PROJECT SUMMARY/ABSTRACT
Prostate cancer information shared through popular social networks such as YouTube, Instagram and TikTok is
widely viewed but misinformation is common. This has important implications for informed decision-making and
quality of life. Exposure to misinformation is an understudied and potentially modifiable contributor to health
inequities in prostate cancer among Black and Hispanic men. The U.S. Surgeon General recently issued an
advisory that spread of misinformation is a serious threat to public health, calling for more research to tackle
misinformation. We will address this research gap through three key approaches: (1) We will examine the most
common types of misinformation being shared about prostate cancer through social media in English and
Spanish. (2) We will also explore how Black and Hispanic men determine whether prostate cancer information
is trustworthy. (3) We will conduct a randomized trial to test the efficacy of a general media literacy intervention
and a health literacy intervention to reduce trust in misinformative prostate cancer content among Black and
Hispanic adults. Our multi-disciplinary team is well-suited to lead this study with expertise in prostate cancer
clinical care, biostatistics, epidemiology, health literacy, health equity, and social media. Our advisory board
includes multi-disciplinary patients, experts and community leaders, all of whom will be involved in all stages of
the research design and in the public dissemination of results. The expected outcomes of this study will advance
the field and promote health equity by studying ways to address the widespread dissemination of misinformation
about prostate cancer.

Public health relevance
PROJECT NARRATIVE Misinformation about prostate cancer is widely disseminated on popular social networks, and it is unknown to what extent this plays a role in the observed health disparities among Black and Hispanic men. We will study the types of misinformation about prostate cancer being widely disseminated on social media in English and Spanish, its implications for decision-making among Black and Hispanic men with prostate cancer or at-risk for prostate cancer, and whether a brief media literacy intervention or health literacy intervention helps to mitigate the impact of misinformative content. Our proposed work seeks to advance health equity for Black and Hispanic men by identifying and addressing the problem of online misinformation about prostate cancer.